Optimizing Supportive Care for Patients with Metastatic Lung Cancer in the Era of Precision Oncology

PROJECT SUMMARY
Lung cancer is the leading cause of cancer-related death in the United States, yet precision oncology
discoveries have substantially improved survival and quality of life for a subset of patients. Patients with lung
cancer with targetable oncogenic driver mutations represent an emerging population of patients living with
chronic, life-limiting cancer. Such patients struggle with uncertainty about when their cancer will progress and
how to make decisions about their personal lives and medical care. They also infrequently discuss their
prognosis and preferences for end-of-life care with their clinicians. This proposal details a five-year plan to
develop and pilot test a palliative care intervention that incorporates elements of survivorship care to address
the unmet needs of patients with oncogene-driven lung cancer. Specifically, the aims of this project are to 1)
refine a population-specific palliative care intervention informed by survivorship care for patients with
oncogene-driven lung cancer with feedback from stakeholders (N=15) and an open pilot (N=10); 2) evaluate
the feasibility and acceptability of the intervention in a randomized controlled trial compared to usual care
(N=80), and estimate the preliminary effects of the intervention on patients’ distress related to prognostic
uncertainty, self-efficacy for managing chronic disease, prognostic awareness, and discussions about goals
and values to inform future decision making.
This proposal also details the plans of the candidate, Dr. Laura Petrillo, a palliative care physician-investigator,
to gain mentorship, didactic training, and career development to facilitate her transition to research
independence. Dr. Petrillo’s long-term career goal is to become a leader in supportive care in oncology,
specializing in developing and evaluating supportive care interventions tailored to the needs of patients
receiving novel therapies. This proposal includes Dr. Petrillo’s plans for gaining expertise in 1) behavioral
intervention development; 2) approach to cancer survivorship research and practice; and 3) clinical trial design
and conduct. She will achieve this training through experiential learning leading the proposed project with
guidance from mentors Dr. Jennifer Temel and Joseph Greer, leading experts in palliative care research, and a
scientific advisory team with expertise in oncogene-driven lung cancer, behavioral psychology, palliative care
and survivorship research. She will gain additional skills through coursework in behavioral research methods,
clinical trial design and conduct, and longitudinal data analysis. This project will position Dr. Petrillo to compete
for R01-level funding and launch an independent career leading a research program at the interface of
supportive care and oncology.

Public health relevance
PROJECT NARRATIVE Advances in precision oncology have led to extended survival for patients with metastatic oncogene-driven non-small cell lung cancer (NSCLC), yet metastatic NSCLC remains incurable and patients live with uncertainty regarding their prognosis that leads to distress. This clinical research and career development proposal will support an early stage investigator to refine and pilot test a palliative care intervention that integrates elements of survivorship care for patients with metastatic oncogene-driven NSCLC. The intervention aims to decrease distress related to uncertainty, increase self-efficacy for management of chronic disease, improve prognostic understanding and increase communication about goals and values to inform future decision making among this novel population of cancer survivors living with incurable cancer.